Project 3: Gut microbiome -arsenic- diabetes interactions

ABSTRACT: PROJECT 3
Exposure to inorganic arsenic (iAs) affects large human populations worldwide and leads to a number of human
diseases, including diabetes. Project 3 addresses a fundamental gap in understanding mechanisms underlying
iAs-induced diabetes – specifically the role of the gut microbiome. The association between iAs and diabetes
has been established in numerous epidemiological studies. We and others have also demonstrated that iAs
induces dysregulation of glucose and insulin metabolism in mice. The gut microbiome has a profound effect on
human health through its key role in metabolic regulation, and emerges as a promising target for intervention
and therapeutic treatment in human health. Accumulating evidence supports the role of the gut microbiome and
Farnesoid X receptor (FXR) in the pathogenies and prevention of diabetes in both animals and humans. Our
studies are among the first to demonstrate the functional interactions between iAs and the gut microbiome. Still,
precisely how the iAs-altered gut microbiome affects diabetes risk remains to be determined. In particular, the
molecular mechanisms underlying iAs-microbiome-host crosstalk are largely unknown. This represents a
significant gap in iAs-microbiome research, which also impedes mechanism-based interventions to reduce
arsenic-induced diabetes via targeting the gut microbiome and its metabolic functions. Our central hypothesis
is that modulation of the gut microbiome will serve as a method for reduction of iAs-perturbed metabolic
dysfunction/diabetes. Specifically, iAs-altered gut microbiome disrupts bile acids to inhibit FXR, which in turn
alters gluconeogenesis and insulin signaling. Our robust preliminary data underscore the key role of microbiome-
bile acid-FXR axis in iAs-induced diabetes, and highlight the potential to modulate iAs toxicity by targeting FXR
via microbiome. To test this hypothesis, we will pursue three specific aims: Aim 1: Establish the functional link
between altered gut microbiota and iAs-impaired bile acid metabolism; Aim 2: Determine the effects of inhibited
FXR activation, driven by iAs-induced gut microbiome dysbiosis, on gluconeogenesis and insulin signaling; and
Aim 3: Mediate iAs-induced diabetes via restoring FXR activation by gut microbiome manipulation. Our strong
team (Drs. Lu, Sartor, Styblo and McDermott) has complimentary expertise in iAs toxicity, gut microbiome, iAs
metabolism and iAs-induced diabetes. We use innovative techniques to characterize largely unknown
contributions of gut microbiome-bile acid-FXR in iAs-induced diabetes and the project is in line with the theme
of the UNC-SRP “Identifying novel methods to reduce iAs exposure and elucidating mechanisms underlying iAs-
induced metabolic dysfunction with a vision for disease prevention.” The highly modifiable nature of the gut
microbiome and in-depth mechanistic understanding of the role of microbiome in disease will allow us to develop
new tangible approaches to reduce iAs-induced diabetes by targeting the gut microbiome and related signaling
molecules.

Public health relevance
NARRATIVE: PROJECT 3 The proposed research is relevant to global public health and the national Superfund program as it will study the role of gut microbiome in inorganic arsenic-induced diabetes. Inorganic arsenic is the highest priority contaminant of ATSDR and is affecting millions of people around the world, including vulnerable populations in North Carolina.